Data Core RC2

PROJECT SUMMARY/ABSTRACT – Data Resource Core (RC2)
The overall goal of RC2 is to enhance scientific productivity of investigators and projects
supported by the UConn OAIC, and to external project investigators, by providing ready access
to knowledge, expertise, and services related to study design, data capture, database
management, data analysis, and measurement approaches. RC2 will support research relevant
to Precision Gerontology in 4 functional domains, consistent with the theme of the UConn OAIC,
and to independence of older persons. RC2 will offer individualized services as well as
organized didactic and interactive learning opportunities, and in conjunction with other OAIC
components will manage and provide access to a cross-study database with standardized
measures for generation of new studies. RC2 will provide data-related support to 3 Pilot Studies
in Year 1 as well as 2 Developmental Projects, including an RC2 Developmental Project
featuring single cell RNAseq genomic profiling of PBMCs from metformin-flu vaccine biomarker
data (in Year 1), and analyses linking biomarker data with physical function and frailty measures
from one of the OAIC-supported pilot studies (PESC3; in Year 2).